Native Spirit: Culturally-grounded substance use prevention for Indigenous adolescents

PROJECT SUMMARY/ABSTRACT
American Indian and Alaska Natives (AIANs) experience disproportionately high rates of lifetime substance
use disorder with peak past-year prevalence rates at 16 years of age. AIAN adolescents ages 17 and younger
have a higher prevalence and earlier initiation of drug and alcohol use compared with all other ethnic/racial
groups in the US. Compared to other ethnic/racial groups, AIAN youth have the highest self-reported
depression rates, and in 2014, suicide was the second leading cause of death for AIANs between the ages 10
and 34 years of age. These data demonstrate the need for early intervention to prevent substance use in AIAN
adolescents. Cultural connectedness has been identified as a protective factor against substance use and
depression for AIAN youth while promoting positive self-esteem and healthy identity formation. Culturally-
grounded after-school programs (ASPs) use cultural values and practices as a basis for health promotion and
disease prevention, a form of AIAN prevention. Culturally-grounded program differ from other cultural programs
(culturally-based or culturally-adapted) because the development is guided or led by the local community, for
the local community and are rooted in specific social and cultural contexts. This study builds on a 6-year
partnership with ASPs serving AI adolescents to assess the impact of a 13-session culturally-grounded
intervention, called Native Spirit (NS). NS is an ASP that is led by traditional knowledge holders with each
session focusing on a community-specific cultural value and activity. NS aims to decrease and prevent
substance use by enhancing protective factors, including strengthening cultural identity, self-esteem, and
resilience. The goals of the proposed (R00) study are to: 1) strengthen self-esteem, resilience, and cultural
identity, and 2) attenuate substance use among AI youth (ages 12-17) through participation in NS. This study
will use a mixed methods waitlist control design to evaluate the impact of participation in the NS program. The
study will measure changes to participant self-esteem, cultural identity, resilience, and substance use with a
self-report survey at three timepoints and semi-structured interviews. This study provides an innovative
connection between cultural engagement and substance use prevention for AI adolescents and also highlights
unique opportunities for health promotion with collaborations with ASPs that serve AI communities. Through
the MOSAIC K99/R00, I will gain training in qualitative and quantitative analysis, culturally-appropriate
measurement of adolescent substance use, and the development and implementation of prevention
interventions while transitioning to an independent investigator in a tenure-track faculty position. The resulting
R00 phase research aligns with NIDA Strategic Goal 2 to “develop new and improved strategies to prevent
drug use and its consequences” with AI communities in the Southwest.

Public health relevance
PROJECT NARRATIVE Culturally-grounded interventions are based on local AIAN values and practices and are promising forms of substance use prevention for AIAN adolescents, yet there is a dearth of studies evaluating their impact. Native Spirit (NS) is a culturally-grounded after-school program that is led by traditional knowledge holders with each session focusing on a unique cultural value and activity. The purpose of this study is to: 1) identify core elements of the NS program, 2) identify and adapt culturally-appropriate assessment measures, and 3) evaluate the impact of participation in the NS program on AI adolescent substance use, cultural identity, self- esteem, and resilience; which will add to the small, yet growing body of work on the relationship between AIAN culture and health.